Core 1: Tumor Processing and Single Cell RNA sequencing Core

Abstract
Single cell RNA-sequencing (scRNA-seq) has emerged as a powerful approach to dissect tumors and
their ecosystems by determining the state of individual cells and inferring partial genetic information
from expressed transcripts. For infiltrating T cells, this provides a comprehensive approach to define T
cell states in human tumors. For malignant cells, scRNA-seq paves the way to characterizing cellular
states and their associated genotypes at cellular resolution. The Molecular Immunology Core (Core 1)
provides standardized and reproducible methods to profile and characterize immune cells and
malignant cells by scRNA-seq in glioblastoma in both patients and mouse models. Core 1 also
provides expert personnel, facilitates the sharing of knowledge within the program, and maintain the
sophisticated equipment necessary to generate data for all Projects. The Molecular Immunology Core
will be led Dr. Mario Suvà and Dr. Kai Wucherpfennig who will contribute their expertise in single-cell
technologies and immune cell isolation.

Public health relevance
Narrative The Molecular Immunology Core provides centralized single-cell RNA-sequencing expertise to characterize immune cells and malignant cells in glioblastoma. We will provide know-how to profile both clinical samples and mouse models with these techniques, serving all projects.